Training in Functional Magnetic Resonance Imaging

DESCRIPTION (provided by applicant): We propose to continue to offer an annual two-week short course on functional Magnetic Resonance Imaging at the University of Michigan in August of each year. This course is fully the same as a semester-length course, but is offered at a convenient time and in a compact format that readily fits into the schedules of graduate students, medical residents, post docs, and faculty. The curriculum covers the physics of MRI and fMRI, coverage of data acquisition, a detailed presentation of issues having to do with experimental design, and substantial coverage of data analysis and interpretation. Students will get the opportunity to design an experiment, acquire data, and analyze those data. The proposed short course will be open to undergraduate and graduate students, post doctoral fellows, faculty, and medical residents. Via the proposed grant, we shall invite 25 attendees from outside the University of Michigan, selected by an admissions committee after extensive recruitment of applicants. The grant will cover travel and subsistence, with no tuition for the course. There is a comprehensive evaluation of the effectiveness of the course immediately after it is complete, as well as an evaluation 8 months later to assess how well attendees have been able to integrate the contents of the course into their research agendas.

Public health relevance
PUBLIC HEALTH RELEVANCE: Functional magnetic resonance imaging of brain processes is an increasingly important diagnostic and research tool for medical and biomedical uses. As a research tool, its use has exploded as more and more is learned about the processing of cognitive and emotional and social and economic information by the brain. Training students, medical residents, post doctoral fellows, and faculty in the proper use of functional MRI via a convenient short course that can fit into their busy schedules will provide a fundamental contribution to the human infrastructure necessary to expand the use of this valuable tool. Project Narrative Functional magnetic resonance imaging of brain processes is an increasingly important diagnostic and research tool for medical and biomedical uses. As a research tool, its use has exploded as more and more is learned about the processing of cognitive and emotional and social and economic information by the brain. Training students, medical residents, post doctoral fellows, and faculty in the proper use of functional MRI via a convenient short course that can fit into their busy schedules will provide a fundamental contribution to the human infrastructure necessary to expand the use of this valuable tool. __SpecificAimsTextDelimiter__ Specific Aims The use of functional Magnetic Resonance Imaging (fMRI) to study cognitive and affective processes in normal and brain-injured populations has exploded in the past 15 years. Consider, for example, the number of papers found in Medline for the years 1994-2008 that include fMRI in the title or abstract, shown in Figure 1. The figure shows that there has been a positively accelerated increase in the use of this imaging technique, indicative of its importance for the study of normal and pathological brain processes. Citatons of fMRI in Title or Abstract 2000 1800 1600 1400 1200 1000 800 600 400 200 0 1994 1995 1996 1997 1998 1999 2000 2001 2002 2003 2004 2005 2006 2007 2008 Year Figure 1 Functional MRI is not a turnkey technique, however; the design of experiments, acquisition of data, analysis of results, and interpretation of findings are each complex activities that require substantial sophistication on the part of the investigator. We propose to continue an intensive summer course to train students and faculty on the use of fMRI for psychological studies. The general aims of the course include the following: • To train basic researchers who study normal and brain-injured participants on fMRI so they can conduct imaging studies at their home institutions • To train medical residents in the fields of psychiatry, neurology, radiology, and physical medicine on fMRI so they can apply the techniques to their own research programs concerning mental health issues • To advertise the course widely to attract a diverse body of participants from throughout the mental health research community in the United States and to support these students financially so they can attend the course In order to achieve these aims, we propose to continue offering a course that we have been offering under the sponsorship of our current R-25 grant that has the following general features: • A two-week curriculum of lectures and laboratories covering (a) the physics of MRI and fMRI, (b) the types of data acquisition routines available, (c) experimental design for blocked and event-related paradigms, (d) post-processing routines that are used on fMRI data, (e) coverage of parametric and nonparametric techniques for data analysis, (e) interpretation of brain activations, (f) a hands-on experiment in which students collect and analyze data, and (g) some tutorial material on reading structural MRI scans to identify brain structures. We note that although this course is encapsulated into a two-week window, it includes sufficiently many hours of instruction and laboratory during those two weeks to be the equivalent of a 3-credit full-semester course. • A recruitment program to select graduate students, postdoctoral fellows, medical residents, academic physicians, and faculty from throughout the United States who are engaged in research concerning cognitive and affective processes. These participants will be selected with an emphasis on including women and underrepresented minorities, and we propose to support their attendance at the course through coverage of travel and subsistence expenses. • A selection program to engage medical residents in the research track of the University of Michigan Psychiatry Department who would benefit from learning techniques of fMRI for use in their own developing research programs; in addition, we shall recruit medical residents from the Michigan residency programs in Neurology, Radiology, and Physical Medicine and Rehabilitation insofar as they may have use of fMRI for their own research programs. • An evaluation of the lectures and laboratories of the course. This evaluation will be conducted in two parts: immediately after the course's termination each year and again 8 months later (with the latter evaluation intended to gather data on whether students have applied their skills to research and clinical problems).